The role of hippocampal neurogenesis in the development of cognitive deficits in autoimmune encephalitis with seizures

Anti-N-methyl-D-aspartate receptor (NMDAR) encephalitis is the leading cause of noninfectious inflammatory
brain disorders in persons younger than 30 years of age. It manifests with confusion, psychosis, and seizures
that may require pharmacologically-induced coma. The most debilitating complication of anti-NMDAR
encephalitis is permanent cognitive failure that occurs in the absence of structural changes on brain imaging or
histopathological evidence of tissue loss; the pathophysiology of encephalopathy remains unclear. Memory
difficulties contribute to poor quality of life in recovering patients; therefore, identifying mechanisms underlying
the loss of cognitive function in autoimmune encephalitis will allow to develop strategies for attenuation and
reversal of these deficits. Emerging literature from animal studies has demonstrated that normal proliferation of
the adult neurogenic stem cells (NSC) in the hippocampus is reduced during prolonged chemically-induced
seizures and spontaneous seizures in Alzheimer’s disease models, and the disruption of neurogenesis occurs
in parallel with memory decline. Further, attenuation of seizures resulted in restoration of neurogenesis and
reversal of memory deficits. We developed a mouse model of autoimmune seizures and showed that mice
develop seizures and memory disturbances during the passive transfer of anti-NMDAR antibodies from
patients. Further, we showed that hippocampal inflammation in encephalitis contributes to the development of
memory deficits; however, the role of neurogenesis in the development of cognitive deficits has not been
explored. This application’s aims are to combine the histological, imaging, and behavioral data to determine
how autoimmune seizures and inflammation affect the proliferation of the hippocampal NSCs in anti-NMDAR
encephalitis. Our first aim is to quantify the cell-specific changes in NSC pool during the sustained exposure to
anti-NMDAR antibodies in our mouse model using immunohistochemical phenotypic markers of neuroprogenitor
cells and stereological analyses (Aim 1a). We will then visualize and quantify the temporal changes in the
hippocampal NSC pool using in vivo positron emission tomography (PET) imaging with 3’-deoxy-3’-[18F] fluoro-
L-thymidine (Aim 1b) and assess the corresponding memory changes using hippocampal-specific behavioral
tests (Aim 1c). Under the second arm, we will visualize the patterns of regional inflammation in the hippocampus
using radiolabeled translocator protein (TSPO)-PET and establish how the extent of the abnormalities on
the brain imaging relates to the memory and learning functions in mice (Aim 2a). With the goal of developing
new therapeutic strategies aimed to attenuate cognitive loss in autoimmune encephalitis, we will determine if
administration of anakinra, an interleulkin-1 receptor antagonist previously shown to decrease hippocampal
inflammation and restore memory in mice, also reverses an aberrant neurogenesis in seizures (Aim 2b). This
successful completion of the project will address a critical gap in understanding the cellular mechanisms of
chronic memory loss in autoimmune encephalitis and will lead to the discovery of new targeted interventions.